IEEE Medical Imaging Conference

Abstract
The IEEE Medical Imaging Conference (MIC) is the leading international scientific meeting
bringing together a broad community interested in the physics, engineering and mathematical aspects of
medical imaging, with special emphasis on nuclear medicine and multi-modal systems. The MIC runs in
conjunction with the IEEE Nuclear Science Symposium (NSS) and the Workshop on Room Temperature
Semiconductor X-ray and Gamma-ray Detectors (RTSD).
The purpose of the MIC is to disseminate and foster new research in physics and bio-engineering
methods in medical imaging. While the traditional topics of primary interest are related to nuclear
medicine techniques such as positron emission tomography (PET) and single photon emission
computerized tomography (SPECT), increasing space will be also given to recently evolving imaging
modalities such as X-ray, CT, optical, MR, with special emphasis on their multi-modal combination with
nuclear medical imaging. Recently there has also been additional interest in employing deep learning
and AI to enhance the field medical imaging. The conference provides a well-established forum of
scientific exchange and dialogue between researchers in academia, industry, and government as well as
education of the public, with special emphasis on young generations. This is reflected by the large
spectrum of educational refresher sessions and short courses. One of the major objectives of the
conference is the education of young investigators, and therefore this NIH R13 proposal seeks $10,000
in funding for each of the next three years to provide 20 trainee grants of $500 each to partially cover
costs of MIC conference registration, housing and/or short course fees for graduate students and
postdoctoral fellows based at US institutions.
We anticipate that the main impact of this grant program will be to increase attendance of students
and postdocs at the 2020 meeting, especially those typically underrepresented, as well as to support
their participation in educational activities. It is important to bring young generations, especially women,
minorities, and those with disabilities, into the medical imaging field, where they could become main
actors in the coming years. They will attend plenary and oral presentations given by many of the world
leaders in the nuclear medical imaging instrumentation, image processing, and quantitative analysis
fields. Moreover, they will be given the unique opportunity of direct personal interaction through the short
courses and dedicated poster presentations. In turn their work will be exposed to the other participants
for critical evaluation, constructive suggestions and dissemination. Furthermore, many of these trainees
will likely continue in this field, thereby contributing to advancing technology with high societal relevance
as being increasingly used in the clinical management of disease and therapeutic interventions.

Public health relevance
Narrative The IEEE Medical Imaging Conference (MIC) has the purpose to disseminate and foster new research in physics and bio-engineering methods in medical imaging. The conference covers a variety of medical imaging topics including quantitative imaging, PET/SPECT techniques, image reconstruction, imaging in radiation therapy, portable imaging, multi-modality systems, new medical imaging technologies, CT/MR/optical/ultrasound, parametric/kinetic image modeling, and signal/image processing and modeling. One of the major objectives of the conference is the education and encouragement of young investigators, and therefore this NIH R13 proposal seeks funding to provide twenty grants for each of the next three years to graduate students and postdoctoral fellows based at US institutions to partially cover costs of MIC conference registration and short course fees.